Microvascular Leakage in Hemorrhagic Shock and Trauma

This R35 MIRA grant application addresses a fundamental gap in understanding of the mechanisms that underlie
trauma-induced microvascular leakage, a hallmark of the systemic inflammatory response. The long-term goal
is to identify novel targets that can be used to ameliorate microvascular leakage in the context of traumatic injury,
in order to improve outcomes for trauma patients. To achieve this goal, the current knowledge of the cellular and
molecular signals that control microvascular permeability must be significantly expanded, including signals that
promote hyperpermeability and those that promote resolution toward normal barrier function. Also, very little is
known about how alcohol intoxication, which often accompanies traumatic injury, worsens microvascular leakage
leading to poorer outcomes for trauma patients. Until these gaps in knowledge are filled, physicians will not be
able to shift beyond current therapeutic paradigms to the next level of care required to save many patients that
worsen over time after trauma, developing sepsis and multiple organ failure. To significantly expand the current
knowledge base of how microvascular hyperpermeability develops and is resolved, the proposed research
capitalizes on emerging approaches that have become more widely available. These include RNA-Seq,
proteomics, metabolomics, and lipidomics, which provide unbiased analysis of changes in expression of genes
and the molecular landscape. Applying these methods to experimental models of trauma or cells/tissues from
trauma patients will identify novel molecules associated with trauma-induced microvascular hyperpermeability
that will reveal answers to three key questions that must be addressed in order to advance new therapies: 1)
Which endothelial signals activated by alcohol intoxication and hemorrhagic shock sustain increased
microvascular leakage, and which terminate microvascular hyperpermeability? 2) Can sustained microvascular
hyperpermeability be accurately predicted and monitored using plasma biomarkers of endothelial injury or
leukocyte activation, to help guide therapeutic interventions? 3) How can fluid resuscitation be optimized to
reduce microvascular hyperpermeability, improve blood-tissue exchange, and better prevent organ dysfunction?
A multilevel approach will be used to answer these questions featuring an established, clinically relevant rodent
model of combined alcohol intoxication and hemorrhagic shock/resuscitation, supported by cultured endothelial
cell models that will increase the depth of understanding about how the microvascular endothelium responds to
trauma/shock. This proposal also leverages the PI’s unique expertise with isolating intact venules for study, and
to maximize translational impact will utilize a novel human isolated venule permeability model. Finding answers
to these key questions is important, because having comprehensive knowledge of the signals that activate and
terminate microvascular hyperpermeability, the biomarkers involved, or what key factors in plasma are
endothelial barrier-protective, will permit logical development of new, personalized therapeutic strategies to
extend and improve life.

Public health relevance
Project Narrative The proposed research is relevant to public health because it is designed to produce preclinical groundwork for new strategies to reduce elevations in microvascular permeability that worsen outcomes of traumatic injury. The project is relevant to the part of the NIH mission that pertains to developing fundamental knowledge that will help prevent disability and early loss of life.